Conduits: Mount Sinai Health System Translational Science Hub

In the past decade, Mount Sinai has invested significantly in the integrative translational initiatives needed to
advance precision medicine. This included investments in genomics, high-performance computing, clinical
informatics, smart technologies, and computational biology. In concert with institutional strategic goals and
increasing community concerns around environmental toxins and social justice, ConduITS, the Mount Sinai
Institute for Translational Science, has evolved its approach to precision medicine to include a precision
public health framework integrating genomics with key public health domains such as environmental health,
social determinants, and big data team science to more effectively address health equity challenges.
ConduITS will harness unique strengths in research informatics, digital health, genomics, exposomics (the
study of all health relevant environment), and data science to transform engagement and the science of
translation to accelerate discoveries into better health outcomes across the lifespan matched to the needs of
the diverse populations we serve. We will augment ConduITS' role in transforming the local, regional, and
national translational research enterprise by developing and sharing innovative educational programs,
incentivizing transdisciplinary team science in emerging data science fields (e.g., exposomics) and
entrepreneurship, as well as training a diversified workforce on emerging clinical and bioinformatics learning
health system approaches that leverage big data. Our aims cut across the domains serving as organizing
principles for our CTSA hub including: 1) Workforce Development. Evolve learning opportunities promoting
transdisciplinary clinical data science and entrepreneurial activities; 2) Diversity. Advance justice, equity,
diversity, inclusion, and an antiracist mindset as core tenets of socially responsible research and training; 3)
Collaboration and Engagement. Engage diverse stakeholders in all phases of translational research through
accelerator models constituted to address priority community concerns and apply an environmental justice, life
course, and data science framework to drive community-centered solutions: 4) Informatics. Leverage data
science to better coordinate health care delivery with translational research by integrating secure electronic
health records (EHRs), patient reported outcomes, clinical trials management systems, and institutional
biobanks and data repositories, enabling clinical data science research; 5) Methods and Processes. Innovate
and streamline research administrative oversight and processes to minimize roadblocks, ensure quality and
integrity; monitor outcomes and garner feedback from stakeholders to facilitate and enhance participation in
clinical translational research supported by ConduITS, regional CTSA hubs, and the CTSA national network;
and 6) Integration. Incorporate translational research across the lifespan, focusing on perinatal and pediatric
research, geriatric populations, and populations impacted by health disparities; accelerating inclusion of
environment in life course precision medicine via our innovative Exposomics optional function.
.

Public health relevance
Project Narrative: The Icahn School of Medicine at Mount Sinai is submitting this application in response to NOT-TR-20-014 to request supplemental support for the QA/QC Project Manager (PM) for the recently funded Mount Sinai Health System Clinical and Translational Science Award (CTSA) (U54TR004213-01). The PM will provide administrative oversight and develop innovative approaches to streamline processes facilitating the submission of necessary regulatory and other documents for activities requiring formal NCATS Prior Approval including, for example, those related to the Prior Approval Process for KL2 and TL1 scholars and pilot projects that involve human subjects, changes in key personnel, addition of a foreign component, and requests for carryover funds. The QA/QC PM will also be responsible for staff training to assist with these activities over the course of U54TR004213 (07/10/2022 through 06/30/2027).